Assessing the Efficacy of Sexual Orientation and Gender Identity (SOGI) Data Collection.

PROJECT SUMMARY/ABSTRACT
To take the first step in identifying and remedying real-world disparities and inequity among SGM populations,
Moffitt Cancer Center began collecting sexual orientation (SO) in 2016 and gender identity (GI) in 2017 as
standard-of-care demographic items in our electronic patient questionnaire (EPQ). Moffitt is one of the first NCI-
Designated Cancer Centers to collect SOGI as standard-of-care demographics for all patients. All new patients
are required to complete the web-based EPQ prior to, or on the day of, their first visit. EPQ data is integrated
into the electronic medical record, and available at the point of care. To date, SOGI demographics have been
collected on over 110,000 patients and ~3.5% of our patient population are self-identified as an SGM. Leveraging
this valuable and largely unique data resource among NCI-Designated Cancer Centers, we propose the following
Specific Aims to assess completeness of SOGI, identify potential disparities and inequity, address
intersectionality, and identify the benefits and barriers of SOGI data collection. In Aim 1 we will assess
completeness of SOGI data, identify disparities and inequity among SGM patients with cancer, and develop a
real-time SGM dashboard. Patient-level data will be curated from the Moffitt EPQ, local cancer registry,
electronic medical records, institutional databases, and billing and procedure records. Descriptive and
quantitative analyses will be conducted to determine completion rates, modifiers of completion rates, and to
identify potential disparities and inequity among SGM versus non-SGM patients with cancer. The curated data
will be utilized to generate a real-time SGM dashboard to prospectively monitor SOGI completion rates, allow
Moffitt investigators to identify SGM patients for research (i.e., cohort builder), and monitor disparities and
inequity in real-time. In Aim 2 will we assess implementation outcomes, barriers, and facilitators of SOGI data
collection and SGM healthcare delivery. Guided by the Implementation Outcomes Framework and the Health
Equity Implementation Framework, we will use a mixed method approach (secondary data analysis, surveys,
interviews) to evaluate implementation outcomes (reach, acceptability, feasibility, appropriateness) and multi-
level barriers and facilitators that affect implementation among key stakeholders (healthcare providers,
administrators, and patients). The long-term goals of this research are to 1) promote, facilitate, and improve our
ability to conduct SGM cancer research and 2) expand and strengthen the evidence base for cancer care for
SGM populations across the cancer continuum from prevention to survivorship. In this work, there will be
concerted efforts to address issues of intersectionality.

Public health relevance
PROJECT NARRATIVE To take the first step in identifying and remedying real-world disparities and inequity among sexual and gender minority (SGM) populations, Moffitt Cancer Center began collecting sexual orientation (SO) in 2016 and gender identity (GI) in 2017 as standard-of-care demographic items in our electronic patient questionnaire (EPQ). Leveraging this valuable and largely unique data resource among NCI-Designated Cancer Centers, in this Administrative Supplement we propose to assess completeness of SOGI, identify potential disparities and inequity, address intersectionality, and identify the benefits and barriers of SOGI data collection.